Spatial Molecular Imager for Single Cell Imaging

PROJECT SUMMARY/ABSTRACT
We are requesting funds for a NanoString CosMx Single Molecule Imager (SMI) to support spatial -omics in
the Institute of Genomic Medicine (IGM) Genomics Center at the University of California, San Diego (UC San
Diego). The CosMx SMI will be placed in the IGM Genomics Center, a campus-wide core facility managed by
the IGM. The highly trained staff of the Genomics Center are experienced with cutting edge genomics
technologies, skills which will translate well to spatial-omics. Since the IGM Genomics Center was established
in 2013, we have provided access to genomics technologies to the UC San Diego community, consistently
upgrading equipment and services to keep pace with the latest innovation in the field. Both our team and our
users are excited about spatial -omics technologies, and we are committed to providing access to this cutting-
edge workflow to campus.
The IGM Genomics Center supports the genomics research of 290 NIH-supported investigators from UC San
Diego, as well as neighboring institutions, in the areas of basic, translational, and clinical biomedical research.
We have identified 10 Major and Minor Users across the UC San Diego research community, including
investigators from nine different departments The projects of our Users encompass multiple areas of relevance
to human health including retinal disease, inflammatory bowel disease, wound healing, neurobiology,
immunology, neural degeneration and reproductive science. The data generated on the CosMx SMI has the
potential to uncover novel disease mechanisms and potential new treatments for disease.
UC San Diego has demonstrated a strong commitment to the advancement of genomics research and the IGM
Genomics Center is determined to continue to provide cutting edge technologies and technical expertise to the
local research community. With the support of our institution and our qualified staff, we will
ensure that the CosMx SMI is properly maintained and used to its full potential.

Public health relevance
PROJECT NARRATIVE This proposal seeks funding for the purchase of a Nanostring CosMX SMI. This instrument is the preeminent instrument on the market for single-cell spatial -omics. Using this instrument, the positional context of transcriptional activity as well as proteins within cells in intact tissue can be assessed, leading to new insights in our understanding of cell-to-cell interactions and functional organization of tissue.